(8) Genomic determinants of the T-cell regulome in immune checkpoint blockade

RESEARCH SUMMARY
Immune checkpoint blockade (ICB) therapies—including ipilimumab (IPI; developed against cytotoxic T
lymphocyte-antigen 4), nivolumab (NIVO; anti-programmed death 1 antibody) and their combination
(IPI/NIVO)—have demonstrated durable survival benefits in melanoma. Despite high response rates, >50% of
patients do not respond to these treatments. In addition, patients often develop immune-related adverse events
with severe morbidity, substantially reducing quality of life. Efforts to identify biomarkers of ICB outcomes have
mainly centered on the tumor microenvironment because anti-tumor T cell immunity is the primary target of
ICB, the focus has been predominantly on tumor T-cell infiltration. While promising tumor-based surrogates of
ICB have been proposed, none of these markers alone or in combination fully explains variability in ICB
outcome. Hence, there is a continuing need to identify more powerful biomarkers of ICB outcomes that would
also serve as potential novel targets for more effective and less toxic treatments. We propose a novel
hypothesis that ICB outcomes are strongly impacted by host immunity, shown in recent reports to be
influenced by underlying inherited factors. It was demonstrated that phenotypic variation in T-cell subsets,
including CD8+ T cells, is attributed to germline genetic variation. In a recent study, we showed that this
inherited component maps to the non-coding regulatory genome, impacting transcriptional regulation of T-cell
differentiation and function. Based on these data, we hypothesize that circulating CD8+ T cells, a primary target
of NIVO and IPI/NIVO therapies, are controlled by germline genetic variation in the CD8+ non-coding regulatory
genome (regulome), and that this genetic variability modulates ICB efficacy and toxicity. The goal of the
proposed study is to discover inherited signatures of the CD8+ T cell regulome that predict ICB efficacy and
toxicity. Using samples from 600 melanoma patients from a clinical trial of NIVO and IPI/NIVO, we will perform
a comprehensive analysis of whole-genome sequencing (WGS) and a whole-transcriptome analysis on
peripheral blood pre-treatment CD8+ T cells to identify non-coding transcriptome signatures that predict ICB
efficacy (Aim 1). We will use the genetic information from WGS to comprehensively assess open chromatin
states in pre-treatment CD8+ T cells from the same 600 patients to identify epigenetic signatures controlled by
inherited genetic variation, predicting ICB response and immune-related toxicity (Aim 2). Our preliminary data
have revealed novel genomic imprints in the non-coding regulome that predict ICB response with high clinical
accuracy, thus substantially supporting our hypotheses and design. For the first time, our study will elucidate
the effect of inherited anti-tumor host immunity on ICB outcomes. As we suggest, besides imminent
applicability to personalized prediction of ICB treatment benefits, the integration of genomic information from
both aims will reveal novel transcriptional networks in CD8+ T cells that potentially affect ICB resistance. These
may eventually serve as novel targets for improved ICB therapies in melanoma and other cancers.

Public health relevance
NARRATIVE A substantial number of patients do not benefit from the promising new immune checkpoint blocking therapies that stimulate the immune system to target melanoma. In our study, we propose to discover the factors that influence response to these novel therapies, providing an opportunity to significantly improve treatment outcomes for patients with metastatic melanoma. ! !